Administrative Core

The ROBIN Oligometastasis (ROBIN OligoMET) Center is focused on understanding how radiation therapy can
affect the metastatic process in low-volume prostate cancer (PCa). The Administrative Core (Admin Core)
leadership will be Phuoc Tran, M.D., Ph.D. (Contact PI) and Isabel Lauren Jackson (MPI). Dr. Tran is Vice Chair
for Research and Professor of Radiation Oncology at the University of Maryland (UM). He is a practicing radiation
oncologist with international recognition for his innovative clinical trials using stereotactic radiation in
oligometastatic PCa. Dr. Jackson is the Director of the Nonclinical Radiation Biology Laboratory (NRBL) and
Director of the Division of Translational Radiation Sciences (DTRS) within the Department of Radiation Oncology
at UM. She has deep experience in managing multimillion-dollar federal contract-research programs on normal
tissue injury and radiation countermeasures. Project leadership comprises a highly experienced and strong
investigative team: Molecular Characterization Trial MCT is led by Drs. Phuoc Tran and Mark Mishra; Project 1
(Genomics, radiomics and liquid biopsies) will be led by Drs. Phuoc Tran, Amit Sawant and Lei Ren; Project 2
(Metabolomics and disparities) will be led by Dr. Nicole Simone Vice Chair for Research and Professor of
Radiation Oncology at the Thomas Jefferson University (TJU); Resource and Cross-Training Cores will be led
by Drs. Luigi Marchionni from Weill-Cornell Medicine (WCM), Amit Sawant and Lei Ren from UM. Supporting
Drs. Tran and Jackson in the Administrative Core will be a Project Manager (Diana Newman). Ms. Newman has
significant experience supporting similar programs including organizing site visits, outreach communications,
organizing symposia, and coordination with NIH, BARDA and DARPA. The mission of our Administrative Core
is to ensure that the research Projects and Research Cores are able to work together efficiently, set priorities for
inter-Project collaborations, validate mechanisms across profiling platforms, and communicate research results
internally and externally. We seek to be dynamic contributors to the NCI ROBIN Program, to collaborate with the
NCI and the cancer research community, and to be a partner with patient advocates to connect basic research
to improved patient outcomes. The leadership of ROBIN OligoMET Center is strongly committed to mentoring
the next generation of leaders in radiation and metastasis research. Our ROBIN OligoMET Center includes two
mid-career emerging leaders as Molecular Characterization Trial Leader (Dr. Mishra) and Core Director (Dr.
Marchionni). Our ROBIN OligoMET Center has funding from the UM Radiation Oncology Department and funds
from UMSOM to target early stage faculty and faculty from backgrounds underrepresented in science (UIS). Our
Admin Core will achieve these goals through three Aims. Aim 1: Scientific and Financial Management of the
ROBIN OligoMET Center. Aim 2: Communication and Review: External Advisory Committee (EAC), Internal
Advisory Committee (IAC), Patient Advocates, and NCI. Aim 3: Pilot Research Grants Focusing on ESI and
Diversity.